PERMEABILITY KINETICS AND NO IN EXPERIMENTAL MENINGITIS

Our overall, broad research mission is to understand the neuropharmacologic and neuroimmunologic modulation of nitric oxide (NO) synthesis in neurodegenerative diseases. Pathological production of NO has blood-cerebrospinal fluid (B-CSF) barrier permeability changes during experimentally - induced meningitis and determine the extent to which NO contributes to this disruption. Preventing B-B and B-CSF barrier changes is important as adverse neurological outcomes are related to alterations in B-B and B-CSF barrier permeability. Moreover, this knowledge may help to develop adjunctive treatment therapies for meningitis. In vivo studies have demonstrated alterations in the B-B barrier were also observed following exposure to bacterial lipopolysaccharides (LPS). LPS is known to induce nitric oxide (NO) synthase in a variety of cell types, including brain endothelial cells and meningeal fibroblasts in vitro. We hypothesize that pathological production of NO may solely or partially contribute to the disruption of the B-B and B-CSF barriers during meningitis. A rat model of meningitis will be induced by the intracisternal administration of LPS. No production will be measured by an ex vivo biochemical technique developed in our laboratory. LPS- mediated alterations in the B-B and B-CSF barriers will be quantitated by in vivo pharmacokinetic methods or in vitro tissue culture methods, utilizing molecular size markers ({14C}-source, {14C}-inulin and {3H}- dextran) which ordinarily do not cross the B-B and B-CSF barrier permeability will be examined under in vivo and in vitro conditions. The specific aims of the proposal are: 1. To further improve the ex vivo technique of measuring central nervous tissue production of NO. 2. To examine the in vivo B-B and B-CSF permeability kinetics of different molecular size radiotracer in relationship to LPS administration and subsequent meningeal production of NO 3. To examine the potential role of NO as a mediator of in vivo B-B and B-CSF barrier permeability kinetics following administration of NO synthase inhibitors or NO generating drugs. 4. TO understand the B-B transport mechanisms of various NOS inhibitors in control and LPS treated rats. These studies could possibly identify novel therapeutic strategies to prevent permeability changes in the B-B and B-CSF barriers in necroinflammatory disease states.